Dissecting the role of ApiAP2 proteins in transcriptional regulation during Plasmodium falciparum development

Although for many years it was thought that Plasmodium parasites, the causative agents of malaria, were devoid of sequence-specific transcription factors, work from our lab and others has now demonstrated that they possess a limited number of such regulatory proteins. The apicomplexan AP2 (ApiAP2) proteins, which are plant-like in their origin, are now widely considered to be the single major family of DNA binding proteins identified in the Plasmodium genome. Our central hypothesis is that members of the ApiAP2 protein family are the major regulators of development throughout the complete lifecycle of the malaria parasite. ApiAP2 proteins are highly variable in size and contain anywhere from one to three AP2 DNA binding domains. We have measured the DNA binding specificities for all AP2 domains from Plasmodium demonstrating a broad array of DNA sequence specificities. By determining the genome-wide occurrence of these DNA motifs, we can begin to predict the functional roles for some ApiAP2 proteins. However, detailed mechanistic studies to confirm these predictions have been lagging. This proposal seeks to define the functional role for a subset of ApiAP2 proteins associated with processes critical to blood-stage development including the regulation of red blood cell invasion, commitment to gametocytogenesis and gametocyte differentiation and maturation. First, we will define the transcriptional regulatory network of PfAP2-G (PF3D7_1222600), which we have demonstrated to be a master regulator of sexual stage commitment. We will also investigate two additional ApiAP2 proteins implicated in gametocyte development (PF3D7_1317200, PF3D7_1408200) to define their role in the regulation of gametocyte differentiation. We next propose to characterize the role of PF3D7_1007700, which we predict to be a regulator of red blood cell invasion. Since PF3D7_1007700 contains three AP2 DNA binding domains, each with unique DNA binding specificity, this will allow us to dissect the contribution of individual AP2 domains to the function of this protein (and other ApiAP2 proteins by analogy). Lastly, we have identified a new conserved domain in ApiAP2 proteins and will initiate efforts to characterize the structure and function of this domain as well as seeking to define transactivation regions within these proteins. To accomplish our goals, we will use a combination of established techniques, including genetic manipulation of the parasite, biochemistry, and genome-wide approaches. Understanding the molecular mechanisms of transcriptional regulatory processes in P. falciparum will provide critically needed tools for studying parasite development, and also presents therapeutic targets for new intervention strategies aimed at blocking parasite maturation. ApiAP2 proteins are strictly found in Apicomplexan parasites and therefore are attractive candidates for new antimalarial therapies.

Public health relevance
Plasmodium falciparum is a eukaryotic pathogen that is the major causative agent for malaria, a disease that afflicts nearly half a billion people worldwide resulting in 1-2 million annual deaths, mostly of children and pregnant women. With the decline in efficacy of the few currently available antimalarial drugs and the lack of an efficacious vaccine, novel anti-malarial intervention strategies are desperately needed. The proposed research aims to better characterize several major transcriptional regulatory networks governing Plasmodium parasite development and, in so doing, define possible new therapeutic targets against this disease.